Cornell Roybal Center-Translational Research Institute on Pain in Later Life

Over the past 5 years, Cornell’s Roybal Center–The Translational Research Institute on Pain in Later Life (TRIPLL) has developed innovative approaches and an effective infrastructure for the translation of behavioral and social science research to improve the health and well-being of older adults. A major strength of TRIPLL is its demonstrated ability to link behavioral and social science research to real-world contexts. TRIPLL has supported the development of behavioral intervention trials that leverage new technologies to bring about adaptive behavior change in the context of pain, an issue characterized by the Institute of Medicine as a critically important and under-addressed public health problem. In this renewal application, we propose to build on our accomplishments to date by measurably expanding the infrastructure of the Center to augment the development of scalable behavioral interventions for pain mitigation. We will maintain program elements that have helped TRIPLL achieve success (e.g., frequent oversight of supported projects) and add new elements (e.g., an Industry Advisory Board to promote collaborations with industry partners and advise on commercializing Center products) to attain additional successes. We will also build on our capacity to test potent and scalable behavioral interventions for pain, targeting specific Mechanisms of Behavior Change (MoBC), and help to advance interventions along the NIH Stage Model continuum with particular emphasis on later stages. The expanded multidisciplinary collaboration among prominent research centers in Ithaca and New York City (NYC), including New York City-based Weill Cornell and Cornell Tech, constitutes a major strength of this renewal application. TRIPLL’s overarching goal is to foster a culture of innovation and achievement that generates new knowledge in behavioral intervention development and effectively moves projects along the NIH Stage Model continuum. We will pursue the following specific aims: 1) Maintain a responsive leadership and administrative infrastructure to support intervention development for later-life pain across the NIH Stage Model, 2) Support and monitor innovative clinical trials that are anchored in the Mechanisms of Behavior Change MoBC and strive to ensure applicability in various groups of older adults; and finally 3) Leverage the intellectual, fiscal, and other resources of the academic and industry collaborators in this application and foster new collaborations with other NIA-funded Centers to achieve synergistic results that would not be attainable by any one institution. The proposed structure of the Center, its clinical trial development program, the support from multiple advisory committees, and the extensive array of resources will help TRIPLL measurably advance the science of behavioral intervention development to address a significant public-health problem: later-life pain.

Public health relevance
PROJECT NARRATIVE – OVERALL Given the continued high prevalence and burden of pain in older people, and the movement away from primary reliance on pharmacological interventions to treat pain, it is crucially important to develop and test treatment alternatives. This proposal seeks to address this need by developing behavioral interventions to mitigate later- life pain with a goal of increasing the health and well being of older adults adversely affected by pain.